Proteostasis at cellular membranes.

Summary (modified parent R35 award) We investigate E3-ubiquitin ligase regulated protein turnover networks in various membrane compartments in mammalian cell systems. Thus, enrichment and purification of various membrane compartments from mammalian cells is essential for understanding the compartment specific protein turn over. Moreover, our understanding of mechanisms of membrane protein turnover networks and their phenotypes regulated by UPS remains sketchy. We engineer mammalian cell systems with various cell-genetic techniques to expose the cell fitness phenotypes, such as cell proliferation and survival, impacted by membrane anchored E3- ubiquitin ligases. Therefore, assays for the measurements of accurate cell number and cell size, in parent and engineered mammalian cells, are indispensable for the cell fitness studies.

Public health relevance
Project Narrative (parent R35 award): Cellular membranes not only compartmentalize intracellular processes, but also serve as the dynamic hubs for the assembly of many multi-protein signaling complexes, oncoproteins, and tumor suppressors. This proposal will investigate the role played by membrane anchored substrate degradation via the ubiquitin proteasome system, modulating communication networks for cell survival and proliferation. The results of this application are expected to impact cancer and cardiac biology.